Airway metabolites shape susceptibility to pneumonia

Abstract
Successful host defense against bacterial pneumonia requires a highly regulated balance between the
activation of sufficient inflammation and oxidants to kill inhaled pathogens and an anti-inflammatory and anti-
oxidant response to protect the host from tissue damage. The ESKAPE pathogens including S. aureus, K.
pneumoniae and P. aeruginosa are multiply antibiotic resistant bacteria associated with substantial morbidity
and mortality in hospitalized patients as the cause of pneumonia and sepsis. These bacteria share a
remarkable ability to alter their own metabolism and that of the host to limit phagocytic clearance and enable
persistent infection. These pathogens robustly stimulate itaconate and fumarate production, among the most
abundant metabolites in the infected airway, both with many anti-inflammatory and anti-oxidant consequences.
We will test the central hypothesis that itaconate and fumarate function in the orchestration of an effective
immune response to these airway pathogens, limiting host damage but at the expense of enabling persistent
infection. We will establish how itaconate is linked to the activation of the major anti-oxidant transcription
factors, Nrf2, Atf3 and their downstream effectors that may interfere with the clearance of S. aureus and P.
aeruginosa by limiting the oxidant tone in the infected airways, important for bacterial killing. We will establish
how itaconate and fumarate skew immune cell phenotypes, promoting the anti-inflammatory M2-like
macrophage and myeloid derived suppressor cell dominated responses. Both itaconate and fumarate are
actively involved in the post translational modification of host and pathogen targets. We will establish how
itaconation and succination of bacterial proteins such as the carbon catabolite repressors enhances the ability
of these pathogens to persist in the infected lung. Our overarching goal is to establish how immunometabolites
contribute to the pathogenesis of persistent airway infection, how different organisms may activate distinctive
responses, and to identify targets to enhance our ability to prevent and treat health care associated
pneumonias.

Public health relevance
Project Narrative The antibiotic resistant ESKAPE pathogens, the major cause of health care associated pneumonia, activate the production of itaconate and fumarate in the airway. Itaconate activates anti-inflammatory and anti-oxidant responses in the host, which protect against tissue damage due to excessive oxidant stress, but also interfere with effective bacterial killing. We will establish how itaconate and fumarate orchestrate both airway defenses and bacteria adaptation in the pathogenesis of pneumonia.